Genetic and Epigenetic Regulation of COMT, a Key Moderator of Cognitive Decline

PROJECT SUMMARY/ ABSTRACT
Although cognitive decline (CD) and impairment are widespread and exact an enormous healthcare burden,
therapeutic options are limited partly due to our incomplete understanding of the neurobiological bases of CD.
Across conditions, including Alzheimer's, and Parkinson's Disease, worsening CD is commonly associated with
high activity of the catechol-O-methyltransferase (COMT) enzyme. Such high activity can occur as a
consequence of genetic variation in the COMT gene. The most studied COMT genetic polymorphism, rs4680, is
an A→G change that yields a 4-fold difference in COMT enzyme activity. COMT breaks down catecholamines,
and is the primary regulator of dopamine clearance in cortical brain regions; it also detoxifies carcinogenic
catechol-estrogens. There are two COMT isoforms, which encode soluble (S-COMT) and membrane bound
(MB-COMT) forms of the enzyme, respectively. Interventions that inhibit COMT can improve cognitive function,
presumably by elevating cortical dopamine. However, while inhibiting MB-COMT, which dominates in the brain,
shows cognitive benefit, no COMT inhibitors to date are isoform selective, and inhibition of S-COMT increases
circulating carcinogenic catechol-estrogens, as well as peripheral catecholamines, increasing hormone-sensitive
cancer risk, and pain sensitivity, respectively. While the evidence is strong that COMT genetic variation alters
enzyme function, growing evidence also points to the influence of epigenetic COMT regulation, e.g., DNA
methylation, in moderating COMT gene expression and bulk enzyme activity. Thus, the ability to selectively
downregulate MB-COMT expression holds tremendous promise as a therapeutic intervention for CD across a
broad array of conditions. Nevertheless, major mechanistic gaps persist: 1) There currently is no efficient way to
distinguish and accurately measure MB- and S-COMT transcripts, and COMT protein isoforms haven't been
measured in tandem with COMT mRNAs; 2) DNA methylation remains to be completely interrogated throughout
regions thought to regulate MB- and S-COMT mRNA expression; and 3) the metabolites driving observed
epigenetic modification of COMT, and their isoform specificity, are unknown. We therefore propose an in vitro
study as a necessary first step in understanding the effects of metabolites and other epigenetic regulators on
isoform-specific COMT expression in human cell lines. We expect to identify compounds regulating COMT, and
their underlying epigenetic mechanisms, which will identify both biomarkers of CD risk and targets for new
interventions for CD. Such future interventions may be particularly useful in combating executive function deficits,
which is an aspect of CD common to a broad array of conditions, including normal aging, multiple
neurodegenerative conditions, schizophrenia, ADHD, PTSD, depression, substance use disorders, and cancer
chemotherapy treatment. As epigenetic marks can be reversed, a better understanding of isoform-specific
regulation of COMT will be transformative in identifying new strategies for treating and delaying CD in these
populations, substantially reducing their clinical and public health burden.

Public health relevance
PROJECT NARRATIVE Cognitive decline is a growing public health problem associated with normal healthy aging, Alzheimer's, and Parkinson's disease; and high activity of the catechol-O-methyltransferase (COMT) enzyme, which can occur as a consequence of genetic variation, or epigenetic factors, is associated with more rapid cognitive decline. Suppressing COMT activity in the brain can improve cognitive function, but peripheral effects of COMT inhibition may increase cancer risk and pain sensitivity; therefore, identifying compounds that can selectively suppress expression of the COMT isoform predominantly expressed in the brain holds great therapeutic promise for treating cognitive decline, and motivates our proposed in vitro study of isoform-specific regulation of COMT to identify genetic/epigenetic markers that predict vulnerability to cognitive decline while providing foundational data for future studies to guide targeted, clinical interventions to ameliorate cognitive decline in multiple populations.